Social Determinants of Adolescent and Young Adult Mortality: New Evidence from Large-Scale Administrative Data

Concerns about deteriorating mental health, substance use disorders, early development of
chronic conditions, exposure to economic shocks, and to violence---causes that may all lead to
premature mortality among adolescents and young adults in the United States, have been rising
in recent public discourse. Despite these concerns, and the importance of this age group for the
society’s future well-being, research on the trends, variation, and above all distal causes of
mortality in this age group has been limited when compared to evidence on the causes and
consequences of mortality among infants and older adults. This dearth of evidence likely stems
from the absence of data sets with wide population coverage for this age group that links
mortality—a very rare outcome—with anything beyond the basic demographic information about
the individuals. In this project, we propose to take advantage of extensive infrastructure for
linking US administrative data that has been developed by the U.S. Census Bureau, to construct
a new database that links administrative birth and death dates for 10 to 25 year olds, with data
on their demographics (race, ethnicity, sex, age, disability status), education, familial
circumstances, parental income, access to public health insurance, healthcare providers, and
local geographies, covering the time period from 2005 to the 2025. Using this new database, we
will document how youth mortality evolved over time and space in the Unites States. We will
also describe mortality inequalities across different subpopulations based on a rich set of
demographic and socio-economic characteristics of adolescents, young adults, their families,
and communities. Finally, we aim to use natural experiments and statistical techniques of causal
inference to improve our understanding of the underlying distal causes of observed mortality
patterns.

Public health relevance
Concerns about deteriorating mental health, substance use disorders, early development of chronic conditions, exposure to economic shocks, and to violence---causes that may all lead to premature mortality among adolescents and young adults in the United States, have been rising in recent public discourse. The magnitude and root causes for these developments are poorly understood. In this project we will construct new large-scale datasets on mortality and socio- economic circumstances of adolescents and young adults in the United States, measure how mortality evolved over time and space, and analyze the contribution of social determinants to observed mortality patterns.